Translational Biomarker Analytical Core

The Translational Biomarker Analytical Core (TBAC) Laboratory makes available to DRC
investigators analytical techniques to support studies of diabetes mellitus, insulin resistance,
intermediary metabolism, and medical consequences of diabetes in human subjects and animal
models. The services provided are best based in a Core Laboratory because they require investigator
consultation, special instrumentation and methods that are difficult or impracticable to establish in
individual laboratories. In addition, this arrangement allows for coordinated attention to reliability and
reproducibility of the assays employed. In investigations of glucose homeostasis, insulin secretion,
insulin resistance, dyslipidemia, hormone action, molecular genetics, or drug effects, it is essential to
be able to monitor hormones such as insulin, C-peptide, glucagon, GLP-1, GIP, PYY, cortisol and
catecholamines and such metabolites as glucose, FFA, glycerol, ketones, amino acids, lipids, as well
as more detailed assessment of the metabolomics fingerprint. With the increasing technical
capabilities to develop and validate novel disease biomarkers, one of the key functions of the Core is
to expeditiously develop and inaugurate these new methods so that the research base can avail itself
of these assays. The SPECIFIC AIMS of the TBAC are: 1) To meet the high demand for a dynamic
range of bioassays by the research base, enhancing efficiency, quality, and reproducibility, while
minimizing costs. 2) To respond to members’ needs by supporting the development of new assays
and methods that leverage the expertise of the Core staff. 3) To facilitate access to targeted and
untargeted metabolomics/lipidomics determinations by the Columbia Irving Biomarker Laboratory and
the newly expanded Metabolomics core. 4) To facilitate access to experts in bioinformatics, kinetic
studies and pathway analyses required to appropriately interpret metabolomics/lipidomics
determinations and stable isotopes kinetic studies. 5) To provide expert advice to investigators and
their associates on analytical methods, experimental design, and data interpretation for state-of-the art
phenotyping of diabetes. 6) To train junior investigators and post-doctoral fellows in practical skills in
the Core methods and, if appropriate, transfer analytical methods to their own labs.7) To facilitate
collaborations among the research base, advertise available resources, and develop and/or facilitate
investigator access to new technologies, such as MS-based methods to analyze and quantify
metabolites. TBAC analytic and consultative capabilities are closely articulated with the other DRC
Cores to provide an integrated approach to quantitative metabolic analyses.